American and Asian Centers for Arboviral Research and Enhanced Surveillance (A2CARES)

ABSTRACT
Recent pandemics of human pathogens have revealed the limitations of current surveillance systems. The
sequential arboviral epidemics in the Americas showed how outbreak detection can be delayed and opportunities
missed to collect well-characterized specimens and data for surveillance, basic science, clinical research, and
development of vaccines and new diagnostics. In response, we have assembled a consortium of world-renowned
investigators in arbovirology, epidemiology, immunology, viral diagnostics, phylogenetics, and clinical research,
while leveraging research infrastructure and expertise in long-term cohort and hospital-based studies. This has
resulted from 3 decades of collaborative international research, with over 200 joint publications, and extensive
experience in preparing for and responding to outbreaks working closely with local and international health
authorities and NIAID. With key sites in Asia and the Americas, we will use innovative molecular and serological
methods to identify emerging pathogens and to address fundamental questions in dengue and other arboviral
epidemiology and test viral, host and environmental determinants of differences between sites along a gradient
of urbanicity. Our overarching goal is to develop an interconnected, harmonized network of clinical and
laboratory sites to strengthen research programs, compare disease epidemiology and severity in
different regions, develop and implement cutting-edge diagnostic methods, and respond efficiently and
effectively to outbreaks. Standardized hospital studies and community-based cohorts in Ecuador, Nicaragua
and Sri Lanka will characterize and compare human arboviral illnesses across urban, peri-urban and rural sites
and develop sustainable infrastructure to rapidly respond to epidemics together with Ministries of Health, comple-
mented by outbreak investigation, surveillance of non-human primates, and vector incrimination. We will imple-
ment standardized plans for study administration, data and clinical management, and statistical analysis across
sites, supported by an extensive on-site training program. Aim 1 will establish standard and novel multiplex
assays at each site for surveillance, diagnosis and research of arboviruses and other pathogens. Aim 2 com-
pares dengue/arbovirus epidemiology and transmission in cohort studies located in ecologically distinct regions
over a continuum of urbanicity. In Aim 3, we will characterize complete viral genome sequences for comparative
studies of arboviral phylogenetics, phylogeography and molecular epidemiology. Aim 4 consists of surveillance,
identification, and characterization of novel and unrecognized human pathogens from severe hospitalized cases,
unexpected outbreaks, vectors and non-human primates. Molecular and serological assays will be developed
for newly identified pathogens and quickly implemented across study sites to characterize the epidemiology and
clinical manifestations and will be made available to the EIDRC network. In sum, our A2CARES Consortium will
provide valuable new tools and knowledge and 3 interconnected centers in Latin America and South Asia that
will be able to respond to outbreaks and to study emerging and endemic infectious diseases far into the future.

Public health relevance
NARRATIVE Recent pandemics have demonstrated the capacity of human pathogens to rapidly emerge to cause widespread outbreaks with new, and potentially severe clinical outcomes, emphasizing the urgent need to put in place flexible and coordinated systems that can quickly respond to the emergence of new pathogens in any region and provide high-quality clinical data and specimens for multidisciplinary research efforts. The overarching goal of this proposal is to develop an interconnected, harmonized network of clinical and laboratory sites in Ecuador, Nicaragua, and Sri Lanka to provide the foundation for research programs at individual locations, compare arboviral diseases across geographic regions, develop and implement cutting-edge molecular and serological testing methods, and respond efficiently and effectively to new disease outbreaks. This Asian and American Centers for Arbovirus Research and Enhanced Surveillance (A2CARES) Consortium will provide valuable new tools, knowledge and sites to the Emerging Infectious Disease Research Center (EIDRC) Network.